Using scalable ultrasonic nano-emulsification to improve pharmacokinetic properties of the natural product curcumin.

Nearly 90% of drug candidates in the pharmaceutical pipeline, 40% of FDA-approved drugs, and most natural therapeutics suffer from poor water solubility, resulting in low bioavailability and inconsistent efficacy. Natural compounds like curcumin, despite their therapeutic promise, are often avoided due to these limitations. Nano-formulations, which encapsulate hydrophobic ingredients in nanometer-sized particles dispersed in water, enhance solubility, improve bioavailability, and ensure compatibility with oral and other administration routes.
Conventional nano-formulation technologies, however, face significant challenges. "Top-down" methods are resource-intensive, with high costs, low productivity, and complex maintenance, while "bottom-up" approaches rely on synthetic ingredients that underperform in the nutraceutical market and may pose risks of adverse reactions. To overcome these barriers, Industrial Sonomechanics has developed its patented Barbell Horn® Ultrasonic Technology and a novel formulation development process, enabling efficient, scalable, and cost-effective production of nanoemulsions. This comprehensive approach powers the creation of all-natural, pleasant-tasting formulations that improve marketability and therapeutic consistency.
Our long-term goal is to enable the effective use of therapeutically important natural ingredients in disease treatment. In this project, we focus on curcumin, a natural therapeutic with extensive clinical research highlighting its potential to treat a wide range of diseases. Despite its promise, curcumin’s extremely low oral bioavailability has limited its therapeutic applications. Until now, overcoming this barrier while maintaining an all-natural product composition—crucial for consumer acceptance and market viability—has remained unattainable. We have successfully developed the first all-natural, cost-effective, and pleasant-tasting curcumin nanoemulsion with a sub-100 nm median droplet size—a key parameter proven to enhance stability and dramatically improve bioavailability.
The remaining challenge lies in characterizing our nanoemulsion’s bioaccessibility, permeability, and stability. This study addresses these gaps, enabling a deeper understanding of its therapeutic potential. By combining enhanced bioaccessibility with an all-natural composition, pleasant taste, low cost, and long shelf life, this product offers superior consumer appeal compared to current alternatives.
Beyond curcumin, this breakthrough underscores the transformative potential of our technology to enable scalable, highly bioavailable nano-formulations for a broad range of natural therapeutics, paving the way for effective, marketable solutions in disease treatment.

Public health relevance
Poor water solubility limits the bioavailability of many therapeutics, including curcumin, a promising natural compound with significant potential to treat various diseases and improve public health. We have developed a first-of-its-kind all-natural, cost-effective, and pleasant-tasting curcumin nanoemulsion, achieving a sub-100 nm median droplet size—a parameter proven to dramatically improve bioavailability and stability. We propose to validate this product’s bioaccessibility, permeability, and stability, addressing the key remaining gap in realizing its full therapeutic potential. This work supports commercialization and broader application of our technology to streamline scalable production of highly-bioavailable natural nano-formulations with broad public health impact.